Montana IDeA Community Engagement Core, Center for American Indian and Rural Health Equity (CAIRHE)

The Center for American Indian and Rural Health Equity (CAIRHE) achieves its research mission through
multidisciplinary community-based participatory research (CBPR) that is considerate of and consistent with
communities’ cultural beliefs. Community involvement in every phase of the research, from design to
dissemination, results in the most effective inquiry and intervention because the greatest knowledge of the
health disparities plaguing Montana’s frontier region resides in the communities themselves. Since its
inception, the Center has relied upon strong community engagement to build effective community-investigator
partnerships across Montana, including seven Indigenous reservations and many isolated rural areas, and to
train investigators in best practices of CBPR. CAIRHE has developed a growing network of communities,
health care providers, public health agencies, and other stakeholders working together to improve health
outcomes for Montana’s most vulnerable populations. Beginning with COBRE Phase I, CAIRHE and its
Institutional Development Award (IDeA) partner at MSU, Montana INBRE, formed the innovative Montana
IDeA Community Engagement Core (CEC). Through shared resources and cross-program collaboration, the
CEC eliminates redundancy between the two IDeA programs, and it enables cost efficiencies and more
conscientious stewardship of taxpayer resources. Continuing throughout Phase III, CAIRHE will contribute to
the success of the Core through its support of Community Research Associates, development of Community
Advisory Boards, maintenance and management of the Core’s Health Education and Research Bus (HERB),
and implementation of the new Core Business Plan. In addition to the CEC’s existing portfolio of training tools
spanning introductory to advanced topics, the Core will create an online hub for training researchers in best
practices for community-engaged research with rural and tribal partners. The Core is working with partners at
the Institute of Translational Health Sciences (ITHS) at the University of Washington and the Huntsman Cancer
Institute at the University of Utah to apply expertise on both sides to build a solid educational platform for
investigators. Finally, the Core will leverage CAIRHE’s Health Equity Network to increase the dissemination,
implementation, and impact of research. On the front end of the research process, the Core will offer
academic-community partnership training for disseminating research statewide and regionally. As pilot projects
and other Center-supported studies draw to an end—with the full cooperation of the Center’s community and
stakeholder partners—the Network will help CAIRHE share its successful research outcomes and interventions
so that they can be replicated in other communities in Montana and the Mountain West region facing similar
health challenges. In turn, partners will continue to recommend research needed from CAIRHE investigators to
respond to pressing local and statewide health issues.